A Nucleolar Paradigm for Pluripotency of Human Embryonic Stem Cells

SUMMARY
This project aims to establish a novel mechanism of human stem cell pluripotency control through nucleolar
structure integrity for functional ribosome biogenesis (RiBi) and proper genome organization/gene expression,
regulated by the nucleolar DEAD-box (DDX) RNA helicase DDX18. This paradigm contrasts with the extensively
studied direct transcription and translation control by well-established transcription factors and translation
regulators in the nucleoplasm and cytoplasm. The nucleolus has mystified the research community for centuries
due to the elusive biophysical principles governing the well-known subcompartmental organization and limited
molecular tools interrogating their nuclear functions. Much work on the nucleolus has focused on its role in
regulating RNA polymerase I (RNA Pol I) transcription and ribosome biogenesis; however, emerging evidence
points to the nucleolus as an organizing hub for many nuclear functions, accomplished via the shuttling of
proteins and nucleic acids between the nucleolus and the nucleoplasm. As a result, we know very little about
how the nucleolus maintains its membraneless structural integrity necessary to control stem cell-specific RiBi
and translation rates, as well as genome organization and gene expression. With the new technology that is
becoming available in studying biomolecular condensates and the realization of the roles of DDX RNA helicases
in cellular RNP condensates and RNA metabolism, this project will address novel nucleolar functions in
controlling conventional hESC pluripotency. Notably, nucleolar functions beyond the RiBi, such as the regulation
of nuclear architectures and genome stability in shaping cellular identities, have just begun to be appreciated,
providing a window of opportunity to explore a paradigm of pluripotency control beyond the well-established
nuclear transcription and cytoplasmic translation machinery. DDX18 is unique among many RNA helicases as it
is strictly nucleolus-specific, and its depletion alters gene expression through the impairment of the nucleolus
integrity pericentromeric heterochromatin reorganization, providing new evidence supporting the functions of the
nucleolus as an inter-chromosomal hub for 3D chromatin organization within ESCs. We hypothesize that DDX18
interacts with specific nucleolar partner proteins and snoRNAs/rRNAs to maintain nucleolar integrity and genome
architecture for controlling the pluripotency of hESCs. We propose two aims to test this hypothesis. 1) Define
the molecular traits of DDX18 in modulating LLPS for nucleolar structure integrity in hESCs. 2) Establish the
nucleolar functions of DDX18 in the organization of chromatin and gene expression to maintain hESC
pluripotency. 3) Dissect the roles of nucleolar DDX18 protein partners and RNA targets in maintaining nucleolar
structure integrity and hESC pluripotency. Upon the completion of this project, we will establish a novel paradigm
in which a nucleolar RNA helicase, namely DDX18, coordinates phase separation and chromatin organization
through its unique biophysical properties and functional partnerships with nucleolar cofactors and RNAs in
controlling human pluripotency.

Public health relevance
RELEVANCE DDX RNA helicases or ATPases are involved in virtually every RNA metabolism step, from ribosome biogenesis to transcription, RNA maturation, microRNA processing, translation, and RNA degradation. This project will unravel the underlying mechanisms of the nucleolar specific RNA helicase DDX18 in controlling nucleolar integrity for pluripotency of human embryonic stem cells, establishing a novel paradigm for cell fate control and providing insights into developing therapeutics targeting the nucleolar dysfunction in human diseases such as ribosomopathies.